Targeting Transcriptional Elongation in Pediatric Glioma

PROJECT SUMMARY/ABSTRACT - Diffuse intrinsic pontine glioma (DIPG) is one of the most devastating
pediatric cancers. Numerous clinical trials in decades, involving different combinations of chemotherapeutic
agents and radiation, have been ineffective in treating DIPG. The identification of efficacious therapeutic targets
based on the molecular characteristic is of high importance for improving treatment outcomes for children with
DIPG. The discovery of oncogenic histone gene mutations in DIPG has dramatically improved our understanding
of disease pathogenesis, and stimulated the development of novel therapeutic approaches to target epigenetic
modifiers. We have recently shown that targeted bromo- and extra-terminal (BET) domain protein 4 (BRD4)
activity using JQ1 inhibitor results in a significant delay of tumor progression and prolonged survival of animals
bearing DIPG patient-derived xenograft (PDX). Because of their promising anti-tumor activity, BRD4 inhibitors
are being tested in a number of cancer patient clinical trials. However, tumors that initially respond to small
molecule inhibitor therapies, such as those targeting BRD4 activity, eventually become resistant to monotherapy
treatment, affirming the need for more effective therapeutic interventions. In order to identify new effective
therapeutic targets, and discover novel combinatorial approaches to prevent or delay acquired resistance to
monotherapy, we performed an unbiased genome-wide CRISPR/Cas9-based genetic screen of patient-derived
DIPG cells. We identified nine “network modules” that are significantly enriched in CRISPR targets. One of these
modules includes POLR2I, which encodes a subunit of RNA polymerase II (Pol II) that is involved in transcription
elongation. We subsequently observed that targeting POLR2I activity through short-hairpin RNA knockdown and
treatment of the small-molecule Pol II inhibitors block transcriptional elongation and inhibit the growth of DIPG
in vitro and in vivo. Here, we will test the hypothesis that inhibition of Pol II transcriptional elongation in
combination with BRD4 inhibition will further suppress gene transcription and will either delay or prevent DIPG
from acquiring resistance to monotherapy. This dual inhibition approach will interfere with gene transcription at
two levels: transcriptional initiation (BRD4) and elongation (Pol II). This project will also explore how these
targeted therapies interact with radiation in treating DIPG, which is important due to the use of radiation in treating
nearly all cases of DIPG in children. The successful completion of proposal study has significant impact on
clinical practice and accumulating data from this research could therefore lay the foundation for early clinical
trials of this approach, given the high unmet need and orphan disease status of DIPG.

Public health relevance
PROJECT NARRATIVE - This research will be the first to provide a proof-of-principle demonstration that targeting transcriptional initiation and elongation is an effective therapeutic strategy in diffuse intrinsic pontine glioma (DIPG), one of the most devastating childhood cancers. This project will also explore how a novel combination therapy interacts with radiation, which is important due to the frequent use of radiation in treating DIPG patients. The successful completion of proposal study will ultimately lead to improved treatment outcomes for patients afflicted with a currently incurable pediatric brain tumor, that is therefore relevant to public health and the mission of the National Institute of Neurological Disorders and Stroke (NINDS), which is to seek fundamental knowledge about the brain and the nervous system and to use that knowledge to advance cures for neurological diseases.